Technology-based Treatments for Substance Use Disorders

OVERALL CORE CENTER PROJECT SUMMARY
Digital therapeutics that deliver science-based, behavior change interventions targeting substance use
disorders (SUDs) and related issues (including HIV risk behavior and mental health disorders) can markedly
improve access to care, quality of care, and treatment outcomes, while reducing costs, for a wide array of
audiences in diverse settings. Our interdisciplinary group received a P30 “Center of Excellence” grant from
NIDA 9 years ago to launch a new research center (the Center for Technology and Behavioral Health [CTBH]).
CTBH has led the field in the development, empirical testing, and implementation of digital therapeutics
targeting SUDs and related issues. In this renewal application, we propose to build on this work and grow
activities to address the most timely and significant research priorities for the field to: (1) enhance our
collaborative work with a wide array of scientific, clinical, industry, and governmental partners to scale access
to science-based digital therapeutics across the U.S. and beyond; (2) expand activities to link CTBH’s
innovative research in digital health measurement to inform personalized digital therapeutics; (3) accelerate
research and mentorship on transdiagnostic digital treatments for substance use and co-occurring mental and
physical health conditions (CODs); (4) expand research and resources on digital health ethics and (5) broaden
the diversity and inclusiveness of digital health researchers by increasing mentorship and representativeness
of underrepresented minorities in digital health research. The Overall Aim of the P30 Center is: To integrate
expertise across multiple disciplines and provide an infrastructure to enhance the quality, pace of achievement,
and impact of innovative scientific research that combines science-based behavior change interventions with
state-of-the-science technologies to create, evaluate, and disseminate digital therapeutics targeting SUDs and
co-occurring disorders (CODs). CTBH will achieve this Aim via 5 Cores: (1) The Treatment Development and
Evaluation Core will provide resources and training to enhance the quality, efficiency, and impact of research
and support mechanisms to accelerate the state-of-the science of digital health assessments and therapeutics
(2) The Dissemination and Implementation Core will disseminate research methods and findings and advance
a scientific understanding of successful implementation of digital therapeutics in diverse settings, (3) The
Emerging Technologies and Data Analytics Core will enhance education and research on the application of
emerging technologies and data analytics to digital therapeutics and support shared resources to enhance the
pace of development, and potency of, digital therapeutics, (4) The Pilot Core will support the development of
new areas of research that could progress to larger-scale testing via external funding after the pilot phase, and
(5) The Administrative Core will provide programmatic leadership that ensures successful coordination of
activities across Cores and an infrastructure to enhance synergy among our interdisciplinary team.

Public health relevance
OVERALL CORE CENTER PROJECT NARRATIVE Behavioral treatments delivered on digital platforms can scale-up access to substance use disorder (SUD) care at a population level and reduce the striking disparities in treatment access and treatment quality evident across healthcare settings. The Center for Technology and Behavioral Health will continue to serve as a national and global leader in the field of digital therapeutics for SUDs by accelerating the development, evaluation, and implementation of scalable, science-based treatments for SUDs while training the next generation of SUD researchers in digital health research.